Diabetes Research Center

ABSTRACT: Center Overview
The mission of the Washington University School of Medicine (WUSM) Diabetes Research Center (DRC) is to
support and enhance research in diabetes and related metabolic diseases. The DRC accomplishes this
mission through Biomedical Research Core services reflecting the evolving needs of diabetes investigators,
vibrant Pilot & Feasibility Programs, and a dynamic Enrichment Program. Now in its 40th year of continuous
NIDDK funding, this DRC is located at an outstanding research institution with a longstanding tradition of
excellence in diabetes investigation. The WUSM DRC Research Base is organized in four Focus Groups:
Metabolic Regulation, Islet Biology & Immunology, Prevention & Epidemiology, and Complications.
Investigators from each group participate in DRC programs that address the Center's central scientific theme
of enhancing approaches across the translational spectrum. There is compelling evidence that the WUSM
DRC is successfully pursuing its mission of supporting and enhancing research, including outstanding
productivity as measured by both by scientific publications and peer-reviewed funding in diabetes and related
research. Our research strategy will build on these accomplishments by:
1. Creating an environment that supports important as well as innovative research in diabetes and related
metabolic disorders;
2. Supporting cutting edge basic and clinical research related to the etiology, pathogenesis, prevention
and cure of diabetes;
3. Raising awareness and interest in fundamental and clinical diabetes research in addition to enhancing
multidisciplinary approaches to diabetes and its complications; and
4. Translating new knowledge in diabetes to improved treatment of patients with diabetes.

Public health relevance
NARRATIVE: Center Overview Diabetes and related metabolic disorders of obesity, insulin resistance, and metabolic syndrome are complex, systemic conditions involving environmental and genetic influences. The infrastructure and support of the Washington University DRC, as well as its nurturing and collaborative nature, are designed to foster multidisciplinary approaches across the translational spectrum to achieve progress in understanding the pathophysiology of these disorders and in developing an infrastructure for developing new treatments, cures and preventive strategies for diabetes and its complications.